Assessing the Impact of Economic Policies on the Use of Pre-Exposure Prophylaxis in the United States

PROJECT SUMMARY
Although
involve
PrEP
case
changes
based,
project will
policies,
secondary impact on condom use and HIV testing.
social-behavioral
their
2
MSM.
PrEP
These
mathematical
policy
such
recent federal and state policies targeted t o encourage PrEP (pre-exposure prophylaxis) — which
(a) enabling pharmacy-based PrEP delivery 1 , (b) leveraging Medicaid program's benefits to promote
(i.e., removal of prior authorization, coverage of telemedicine-delivered PrEP, and overage of targeted
management) 2 , and (c) mandating zero-cost sharing 3 — have been described as the most significant
that have happened with PrEP 4 – , their impact is not well understood. By implementing a theory-
multi-level, longitudinal analysis of how public health policies
identify policies to efficiently achieve the Ending the HIV Epidemic goals. – 13 Aim 1 will integrate
prescription data, surveys, and consumer data to isolate the effects of the policies on PrEP use
Aim 2 will expand our longitudinal database to include
determinants of PrEP use, including attitudes, norms, and behavioral control, and explore
mediating role in the relation between public health policies and PrEP uptake and persistence. Aims 1 and
will mode l a) the US population, (b) MSM (men who have sex with men), and (c) Black, Hispanic, and White
Aim 3 will f urther examine the effectiveness of the policies studied in Aim 1 by moving from effects on
t o modeling effects on HIV transmission among MSM in general and Black, Hispanic, and White MSM.
three aims will be achieved through an innovative combination of econometric, big data, tatistical, and
methods. First, a difference in differences method will compare intervention areas in which a
has been implemented and control areas without the policy while adjusting for unmeasured confounders
as differences in culture or demographics. Second, big data analyses
c
6
affect PrEP uptake and persistence, this
7
and
(
s
,
will assess psychosocial
determinants of PrEP use for different regions and investigate the role of the policies in eliciting behavioral
change. Third,
of
important
populations
Award
these results will inform an agent-based model of HIV transmission that will project the impact
the interventions for MSM, taking into account national race/ethnic disparities. Dr. Fayaz-Farkhad has made
contributions to understanding the effectiveness of interventions targeted for marginalized
and is an accomplished junior researcher with ample experience in the field of HIV. This K01
will extend her trajectory with training in several key areas:(i) HIV epidemiology, (ii) the science of
attitudes and behavior, (iii) health inequalities, and (iv) advanced methodological skills.
provide
whose
project
cross-cutting
Behavioral
The proposed K01 will
training and mentorship to serve as the foundation for her career as an independent investigator
research will serve to improve healthcare access for populations vulnerable to HIV infection. This
is well-aligned with NIAID's strategic objectives and directly in line with the Office of AIDS Research
areas of Health Disparities to reduce the incidence of HIV in priority populations and utilize
and Social Sciences for HIV care.

Public health relevance
PROJECT NARRATIVE This project will identify successful PrEP policies for reducing HIV transmission nationally, among MSM, and Black, Hispanic, and White MSM. If successful, the findings will advance the Ending the HIV Epidemic goals and produce actionable data to improve health justice in the United States.